African Rigorous Innovative Stroke Epidemiological Surveillance (ARISES)

PROJECT SUMMARY
Stroke is a leading cause of death and disability globally; but its precise
burden is not clear in Low-and Middle-Income Countries (LMIC) particularly in
Africa. Surveillance systems are almost non-existent in LMIC, where they are
needed most, for reliable determination and tracking of the actual burden of stroke,
its epidemiological trends and outcomes. Unlike other regions, the few available
estimates of the burden of stroke in Africa come from the Global Burden of
Diseases (GBD), which are mostly derived from models using unreliable or scanty
data. Developing a scalable sustainable rigorous active e-Surveillance system
that takes advantage of available mobile-health technology will provide reliable
real-time community-based data on the actual burden and determinants of stroke
in Africa. This will improve early notification and presentation in an appropriate care
facility; and inform the development, implementation and evaluation of effective
community-based stroke prevention, other interventions and policies in Africa and
other LMIC regions, which bear over 80% of the global burden of stroke.
The overall goal of African Rigorous Innovative Stroke Epidemiological
Surveillance (ARISES) is to deploy and validate a first-of-its-kind scalable mHealth
community-based interactive Stroke Information and Surveillance System (SISS)
for reliable measurement and real-time tracking of the population burden of stroke;
while simultaneously building sustainable capacity for improving stroke literacy,
early presentation and outcome in two pre-existing demographic surveillance sites
(DSS): one urban and one rural area in Nigeria.
To achieve this, we will leverage resources we previously created including
1) a stroke video documentary for improving stroke literacy and recognition in
communities, 2) a culturally-appropriate dance routine for sensitization about
stroke, 3) a pictographic tool for screening stroke in communities, and 4) a special
software for accurate rigorous phenotyping of stroke. Furthermore, in 1,095
households in Nigeria, we pilot-tested the key components of the e-Surveillance
system including text messaging platform which clinicians can use to elicit reports
of stroke events remotely and a mHealth platform through which community
members can notify health-workers about stroke occurrence or death. About 99%
of the community members had easy access to mobile phones; while over 95%
expressed ease of communicating via phone calls or text messages, willingness
to report stroke events, and/or have their health monitored via the e-Surveillance
system. To ensure near-total case inclusion and accurate denominator population,
we will continue to map the community sites, update population figures and
demographic profiles, and institute a novel multipronged ‘hot and cold pursuit’ case
ascertainment technique with door-to-door surveys in the selected DSS integrating
orthodox and non-orthodox care systems for sustainability. We will also integrate
the SISS into a sustainable care matrix to improve stroke outcome in the DSS.
The integration of the novel e-Surveillance, community engagement, and
stroke care matrix in ARISES makes it a holistic model, which is scalable to other
low resource-settings in the USA and LMIC to improve the ease, accuracy and
frequency of production of epidemiological indices of stroke burden while also
improving stroke literacy, prevention, early presentation and outcome using
mHealth.

Public health relevance
PROJECT NARRATIVE The absence of reliable data and low research output has been a major setback for evidence-based interventions and policy decisions for the control of stroke in Africa and other underserved low and middle income settings. To combat the apparently increasing burden of stroke in Africa, ARISES will build sustainable capacity for rigorous novel e-Surveillance of stroke in urban and rural settings in order to reliably monitor its burden, trends, and determinants. This scalable system will facilitate prompt notification and early presentation for appropriate care; in addition to the development, dissemination and evaluation of appropriate prevention, interventions and policies to rapidly and efficiently reduce its toll in low income settings in Africa, USA and beyond.